Cancer Research Training and Education Coordination

ABSTRACT
The overall mission of the Cancer Research Training and Education Coordination (CRTEC) core at Roswell Park
is to develop the next generation of cancer research professionals through coordinated implementation of
rigorous educational programs across the training continuum. Consistent with Roswell Park's mission, all CRTEC
education and training programs are cancer-focused. CRTEC is responsible for a comprehensive educational
and training portfolio that includes immersive cancer research experiences for K-12 students, a long-standing
(65+ years) summer internship program for high school, college and medical students, new nurse residency and
nursing scholars program, graduate programs in the Cancer Sciences, postdoctoral training, and oncology-
focused residency and fellowship programs. CRTEC also coordinates a faculty mentoring program and career
development activities to enhance academic productivity and promote a healthy work-life balance. CRTEC
activities are integrated with the cancer center’s mission, informed by our catchment area needs and designed
with a strong commitment to building diversity, equity and inclusion. A combination of sustained institutional
commitment, CCSG-support for research programs and shared resources and a pool of experienced faculty
mentors enable successful delivery of these training programs. Working closely with the Offices of Community
Outreach and Engagement (COE) and Diversity, Equity, and Inclusion (DEI), CRTEC will continue to develop
and implement K-12 cancer educational programs prioritizing diversity. In collaboration with DEI, CRTEC will
facilitate recruitment and retention of underrepresented minority (URM) faculty through culturally responsive
faculty mentoring programs and CCSG/cancer center leadership pipelines. We will continue to measure key
productivity and engagement metrics including programmatic reach, equity and opportunities for improvement
based on trainee and mentor feedback for all CRTEC activities to ensure successful training experiences.